Identifying genetic drivers of circulating metabolites associated with cardiac risk in pediatric chronic kidney disease

PROJECT ABSTRACT
Cardiovascular death is the number one cause of mortality for children with chronic kidney disease (CKD) once
they reach adulthood. There is limited knowledge of the biochemical pathophysiology of left ventricular
hypertrophy (LVH) and ventricular dysfunction (VD), prognostic markers of future adverse cardiac outcomes in
pediatric CKD, and a dearth of targeted or preventive interventions. Metabolite associations with cardiac
outcomes in children with CKD have been identified through plasma untargeted metabolomic profiling in the
Chronic Kidney Disease in Children (CKiD) study. Multi-omics investigations can better elucidate
pathomechanism and have to led to significant discoveries; however, studies in pediatric CKD have been limited.
This proposal builds upon previous metabolomics work by integrating genotyping data to identify causal gene-
metabolite axes with left LVH and VD in pediatric CKD. This work seeks to answer two specific aims, 1) if there
is genetic variation associated with circulating metabolite levels that have been previously associated with
pediatric CKD cardiovascular outcomes and 2) if circulating metabolite levels have causal effects on LVH and
VD in pediatric CKD. Circulating metabolite levels' association with single nucleotide polymorphisms (SNPs) will
be assessed through metabolomics-genome wide association studies (mGWAS) analyses. Metabolite causality
on LVH and VD pathogenesis will be assessed with bidirectional Mendelian randomization, leverage genotype
data as instrument variables. Elucidation of pathophysiology of LVH and VD in pediatric CKD may inform
continued research investigations and development of therapeutic targets, aiding in the eventual prevention and
treatment of cardiac risk factors in this underexamined population in clinical practice. In addition to the scientific
pursuits of this career development award, Dr. Arthur Lee will make significant advances toward developing his
career as an independent clinician investigator. Dr. Lee's career goals are to 1) extend the science of his R38
metabolomics work through the integration of genomics data, 2) gain skills in biostatistics by working with
genomics data and multi-omics analyses, and 3) to continue receiving mentorship and formalized didactical
training in large data-based clinical research. Dr. Lee will meet regularly with his primary mentor and two working
groups, and will receive feedback from his mentoring committee quarterly. Dr. Lee will pursue a Masters of
Science in Translational Research (MSTR), with a concentration in Bioinformatics, which advances future
researchers through didactive coursework, a formal mentorship program, research training, professional skills
development program, and guidance towards protocol and grant development. Completion of this K38 research
will result in abstract submissions to national conferences and first-author manuscripts for each aim. Altogether,
this proposal will serve as a bridge leading to a NIH early career funding proposal, analogous to how the R38
served as a pipeline to this K38 application.

Public health relevance
PROJECT NARRATIVE This proposal will examine how metabolites previously associated with cardiac outcomes in pediatric chronic kidney disease relate to genetic variation, and if they have causal effects on the development of adverse cardiac outcomes, leading to new understanding cardiac biochemical pathophysiology in pediatric CKD.